Defining the novel cancer testis antigen HSPA1L as immunotherapeutic target in AML

SCIENTIFIC ABSTRACT
Acute myeloid leukemia (AML) comprises a genetically and clinically heterogeneous group of
aggressive hematological malignancies. Despite advances in molecular characterization of AML, the majority of
patients will relapse and die of their disease, indicating the urgent need for novel therapeutic approaches.
Recently, antibody-based therapeutics have emerged as an effective tool in leukemia therapy but still in need of
novel targets. Our proteomic studies using blast leukemia cells from different leukemia subtypes, have identified
a putative therapeutic target HSPA1L, as being expressed on the cell surface of AML and other hematologic
malignancies, but sparing normal tissues except for male reproductive system. We validated expression of this
target by flow cytometry and confocal analyses. Our hypothesis is that immune therapy approaches targeting
specific epitopes of the surface protein HSPA1L can selectively eliminate target-expressing AML while
avoiding immune-related adverse effects. Importantly, we have already generated monoclonal antibodies
(MAbs) against HSPA1L, selected positive clones by ELISA and validated cell surface target binding in AML
cells. In this proposal, we will characterize expression patterns of HSPA1L in AML and AML stem/progenitor
cells; and utilize first-time produced monoclonal antibodies for therapeutic applications, by testing antibodies
alone, antibody-drug conjugates or as immune engaged targeted depletion effector function using in vitro and in
vivo leukemia models.
In Aim 1, we will characterize selected candidate antibodies exploring the feasibility of using them alone, to
trigger complement depending cytotoxicity (CDC) or engage effector cells, such as NK and macrophages to
trigger antibody dependent cell cytotoxicity or phagocytosis (ADCC or ADCP); or as antibody-drug conjugates
(ADC) by conjugating MAbs to auristatin. The expression patterns of HSPA1L in AML, and AML stem/progenitor
cells and in normal bone marrow cells and hematopoietic stem cells will be studied.
In Aim 2, we will test the efficacy of the selected lead HSPA1L MAbs with or without conjugation as ADCs in
vivo in bioluminescent-labeled AML cell line models using SCID mice, and in patient-derived xenograft (PDX)
AML models in NSG mice.
We have assembled a multi-faceted team of highly experienced investigators with deep background in MAbs
generation and testing, proteomics and target discovery, pre-clinical assessment of novel agents in adult and
pediatric leukemias in vitro and in vivo models, and clinical translation in adult and pediatric acute leukemias. If
successful, this multi-investigator project will generate novel antibodies for future clinical development in target-
expressing leukemias that will be tested in clinical trials, alone or in combination with standard chemotherapy.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is a blood cancer that cannot be cured with current treatments in more than half of adult patients and in one third of children. Our group has identified a novel protein that is highly expressed on the surface of AML cancer cells and not expressed in normal tissues except in the male sex gland, which represents an ideal target for activation of the defensive pathways in the patient’s body to kill cancer cells. As a proof of concept, we have made a first set of antibodies, reagents that can recognize this novel target, and in this project we will test how newly generated antibodies affect leukemia and elicit a host immune response against human leukemia cells grown in experimental models.